Antibody in Defense Against Neonatal Candida Infections

DESCRIPTION (provided by applicant): Candida albicans is an important cause of invasive infections in the premature neonate. Although the neonate is generally considered as an immunocompromised host, the mechanisms of anti-fungal host defense are poorly defined. Specific antibodies have a role in cell mediated resistance to infection. The long range goal of this proposal is to understand the mechanisms by which specific antibodies may augment host resistance to Candida infection in the immunocompromised neonate. These studies should provide the basis for the development of reagents suitable for passive immunization and additional therapies for these serious infections in patients at risk. The principal investigator is in the first year of a faculty appointment in Pediatrics at Brown University. He earned his M.D. and his Ph.D. in microbiology from the University of Rochester and completed his clinical training as a neonatologist. His graduate and fellowship research was focused on mechanisms of microbial pathogenesis from the perspective of the microbe, and his mentors were basic scientists. This proposal addresses antimicrobial mechanisms from the perspective of the neonatal host. The goals of this sponsored award are twofold. The primary aim is to take advantage of the rich research and training environment at Brown University and its connections with the greater New England region to gain experience in immunobiology. This goal will be achieved through coursework, seminars, and direct mentoring of the research plan with successful and established immunologists. The second aim is to gain expertise in the challenges of maturing as a physician-scientist through a close and sustained interaction in a mentored relationship. The structure and personnel included in this proposal will support the candidate in his long term goal of becoming an established scientist focused on the population to whom he has made his clinical commitment as a physician. As such, he will be in an ideal position to orchestrate the translation of basic science to the benefit of patients.